Population Council Contraception Development Research Center Administrative Core

ADMINISTRATIVE CORE – ABSTRACT
The Population Council (PC) P50 Contraception Development Research Center will convene experts in product
development (including design, formulation, manufacture, and testing), social-behavioral and clinical science,
and regulatory affairs within PC and our academic partners to advance the development our multipurpose
prevention technology (MPT) intravaginal ring (IVR), referred to as the CZL-IVR, to meet the needs of women
globally by providing non-hormonal contraception and STI/HIV prevention as well as optimizing vaginal health.
The Administrative Core (AC) will be at the heart of the P50 Center, providing scientific, executive, and
administrative leadership, allocating resources, and influencing research priorities. The AC will serve as the
primary logistical, supervisory, and operational driver, ensuring smooth functioning of the P50 Center. The AC
will implement an annual strategic planning process with our external and community advisory committees, with
ongoing review and adjustments as necessary, promotion of collaborative teamwork across the P50 projects,
and day-to-day support of the projects and P50 Center overall. The AC will ensure rigor of our science by
providing regulatory oversight and support as well as data management and statistical expertise. Furthermore,
the AC will provide training opportunities and pilot grant funding to support young scientists and early stage
investigators developing careers focusing on contraception and STI/HIV prevention. The AC will leverage the
extensive skills, knowledge, and expertise of its multidisciplinary team of experts and the decades of successful
contraceptive product development at PC’s Center of Biomedical Research (CBR) to establish the P50 Center
and support its activities in order to advance our innovative non-hormonal MPT CZL-IVR.